Sleep Health Profiles Predicting Impaired Cognition and Depressive Symptoms in Older Adults: Extending Novel Statistical Methods in Multi-Cohort Applications

PROJECT SUMMARY / ABSTRACT
Depression has an enormous impact: it is the leading cause of disability worldwide and affects more than 264
million people of all ages. Moreover, major depression at any age doubles the risk of Alzheimer’s Disease and
related dementias, which affect over 50 million people worldwide — a number projected to triple by 2050.
Interventions for depression in older adults have limited efficacy to date, and directly treating cognitive
impairment and/or Alzheimer’s Disease is not feasible or effective. Thus, identifying modifiable risk factors that
favorably influence both depression and cognition before dementia onset is an urgent public health need. Sleep
is one such risk factor. However, sleep is not a uni-dimensional construct represented by merely its duration or
the presence/absence of a sleep disorder. Rather sleep is multidimensional: it is comprised of multiple domains
(e.g., Regularity, Satisfaction, Sleepiness, Timing, Efficiency, Duration) and measured on multiple levels (e.g.
self-report or behavioral [via actigraphy]). In our initial R01, we leveraged our biostatistical and sleep expertise
to develop and hone methods for examining multidimensional sleep health as a predictor of mortality in a high-
dimensional machine learning (ML) context that flexibly accounts for the complex interactions that exist among
sleep and non-sleep risk factors. We now seek to build on the success of the initial funding period by using our
novel methods to examine multidimensional sleep health as a predictor of changes in cognition and depressive
symptoms. To enhance generalizability and power, we are developing a Pooled Sample of N~3,400 adults aged
≥65 without cognitive impairment from the Osteoporotic Fractures in Men Study, Study of Osteoporotic Fractures,
Memory and Aging Project (MAP) and Minority Aging Research Study (MARS). With these methods and data,
we will examine multidimensional sleep health for predicting changes in global cognition and incident dementia
(Aim 1) and depressive symptoms (Aim 2) in a high-dimensional machine learning context. We will also examine
depression as a pathway through which multidimensional sleep health predicts impaired cognition (Aim 3). Our
Secondary Aims are to: (a) apply parallel methods in two additional cohorts (the Rotterdam Study and Multi-
Ethnic Study of Atherosclerosis) to replicate and extend our findings to cohorts with different demographic
profiles and clinical Alzheimer’s Disease and related dementias diagnoses; (b) examine effects by sex and race;
and (c) identify the sleep health characteristics driving overall effects. Identifying multidimensional sleep health
profiles that reliably predict changes in global cognition, incident dementia, and changes in depressive symptoms
in a realistic, high dimensional context will directly inform the design of novel targeted interventions and
prospective studies focused on preventing Alzheimer’s Disease and related dementias. Moreover, we will amplify
the impact of our work by demonstrating new methods for studying health and depositing harmonized data on
the National Sleep Research Resource to facilitate future multi-cohort secondary analyses.

Public health relevance
PROJECT NARRATIVE Depression and Alzheimer’s Disease and Related Dementias are among the leading contributors to morbidity, disability, and mortality worldwide. This project will apply novel machine learning techniques to large multi-cohort samples to determine whether multidimensional sleep health predicts cognitive outcomes (change in cognition, incident dementia; Aim 1) and change in depressive symptoms (Aim 2), and examine depressive symptoms as a pathway through which multidimensional sleep health predicts cognitive outcomes. Through our multi-cohort secondary data analysis approach, which offers enhanced generalizability and power and an efficient use of existing resources, our findings will directly inform the design of subsequent prospective studies aimed at developing integrated approaches to treating depression and cognitive decline in older adults, with implications for preventing Alzheimer’s Disease and Related Dementias.